Research Training in Child Behavior and Nutrition

Our postdoctoral training program at Cincinnati Children's Hospital Medical Center is a central component
of the Center for Child Behavior and Nutrition Research and Training. The Center has a specific research focus
on the behavioral, biologic, and nutritional aspects of pediatric chronic illnesses and other nutrition-related
health issues. The Center's T32 training program, funded by NIDDK in 2003, formalized cross-disciplinary
training at the postdoctoral level with the aim of training the next generation of academic leaders. The training
program integrates the expertise of faculty members across the Divisions of Behavioral Medicine and Clinical
Psychology; Endocrinology; Gastroenterology, Hepatology, and Nutrition; General and Community Pediatrics;
Pulmonary Medicine; Biostatistics and Epidemiology; Neurology; the Department of Pediatric and Thoracic
Surgery; and the Department of Rehabilitation, Exercise and Nutritional Sciences. Trainees acquire: (1)
expertise in the pathophysiology, diagnosis, and treatment of pediatric chronic medical conditions in which
dietary modification is a central component of disease management; (2) knowledge of “state of the art” as well
as innovative means of assessment of physical (e.g., body composition, bone mass, disease progression),
nutritional (e.g., via electronic data capture), and psychosocial (e.g., quality of life, family functioning, functional
behavior) status across the pediatric age range; and (3) knowledge of nutrition, behavioral, and clinical trials
science necessary to develop empirically-tested prevention models and clinical interventions that improve
dietary adherence, nutritional status, and long-term health and quality of life outcomes for youth. Candidates
have backgrounds in clinical psychology, nutritional science, or pediatric medical subspecialties (e.g.,
Endocrinology, Gastroenterology). The focal elements of the training program are mentored experiences within
interdisciplinary research programs with our NIH-funded research faculty. These mentored research
experiences include the fellow's participation as both an interdisciplinary team member, as well as their
initiation of a mentored interdisciplinary independent research project. Based on the fellow's prior educational
pathway (PhD, MD), further training is obtained via practical and applied experiences and engagement in
didactics, seminars, and academic coursework tailored to an individual's training needs and career goals (e.g.,
behavioral science, nutrition science, clinical trials methodology, advanced biostatistics, grant-writing,
responsible conduct of research, Masters Degree in Clinical and Translational Research). As evidenced by the
excellent progress of our program graduates, these training opportunities provide a solid foundation from which
young clinical researchers have already secured, and will continue to successfully transition to, faculty
positions in the field of academic medicine and emerge as leaders with NIH-funded clinical research programs
that have a significant impact on future pediatric health outcomes. The current renewal application (Years 16-
20) for this innovative T32 program requests support for four postdoctoral training positions.

Public health relevance
Nutritional and dietary modifications are key components to the management of many pediatric chronic conditions, yet are often difficult for youth and families to accomplish, causing significant morbidity and reduced life-expectancy. Clinical investigators with knowledge of behavioral, biomedical, nutritional, and clinical trials sciences are critically needed to develop empirically-tested prevention models and clinical interventions that improve dietary adherence, nutritional status, and long-term health and quality of life outcomes for youth. Graduates of this fellowship program will be national leaders who will have a significant scientific impact on research in child behavior and nutrition and relevant health outcomes for many years to come.